A pathophysiology driven spatial dynamic modeling framework for personalized prediction and precision medicine

Abstract
Predictive personalized healthcare and precision medicine enable a new era of medicine, in which traditional
physiological information and new clinical data including genetic data, imaging data, and healthcare data come
together to match the right patient with the right treatment at the right time. With healthcare and clinical
technology rapidly grow, the vast and varied amounts of clinical data become widely accessible and usable.
However, current modeling techniques lack of combining pathophysiology with imaging data. Therefore,
developing an innovative data analytical tool that combines personalized clinical data with the existing sciences
of epidemiology and clinical medicine becomes an urgent need in this new area. The overall vision of this
research project is to develop a pathophysiology driven spatial dynamic modeling (PDSDM) approach for
personalized healthcare prediction and precision medicine. Our five-year goals are to develop the PDSDM
computational modeling platform and validate this platform on patient data for various diseases. In specific, we
will develop an interactive computational platform to build the PDSDM model and develop a computational
module to simulate the model automatically. Then we will develop a model calibration module by employing the
clinical patient data to parameterize mathematical models arising from physiological signaling pathway
networks and will also incorporate the imaging data as the spatial computational domain; moreover, optimal
personalized treatment studies will be performed on this computational modeling platform for current available
clinical trials. This innovative framework will integrate mathematical modeling, computational methods, data
analysis, and data-driven optimization techniques to provide a personalized spatial computational model for
each individual. We will validate this new framework on various biomedical diseases such as cardiovascular
disease, chronic pancreatitis, and Alzheimer’s disease with existing clinical and biological data. The proposed
research is significant because it will provide the 3D prediction for personalized disease progression which
would evaluate personalized disease risk more accurately. It will also provide a systematic way to assess the
available treatment plans virtually then to provide an optimal treatment suggestion for each individual.

Public health relevance
Narrative Predictive personalized healthcare and precision medicine based on both traditional physiological information and modern clinical spatial imaging biomarkers would provide an accurate disease prediction and personalized treatment plan. This proposed project will develop a personalized spatial data-driven computational modeling framework to analyze these clinical biomarker data and will also validate this approach on various diseases. The successful research will have a huge impact to reveal a more comprehensive disease assessment and a new therapeutic approach to optimize the available treatment plans for each individual.